Role of JMJD4 in Breast Cancer

PROJECT SUMMARY – ROLE OF JMJD4 IN BREAST CANCER
In 2023, nearly 43,000 women will die from breast cancer in the US, indicating the urgent need for
better therapies. A more comprehensive understanding of driving forces in breast cancer may furnish novel
ideas how to curtail this disease.
JMJD4 is an enzyme that has been implicated in protein lysine hydroxylation and demethylation.
However, the precise physiological functions of JMJD4 and its mechanisms of action have remained
unresolved. Our preliminary data demonstrate that JMJD4 is upregulated in breast tumors and JMJD4
ablation can reduce growth and invasion of human breast cancer cells. Further, we provide evidence that
JMJD4 interacts with two transcription factors involved in the development of breast cancer and
chemoresistance: the stress response mediator NRF2 and HIF-2a, a major component of the hypoxia
response pathway. This suggests various potential mechanisms by which JMJD4 may affect breast cancer
cells.
Based on these and other preliminary data, we posit that JMJD4 promotes breast tumorigenesis.
Moreover, we hypothesize that JMJD4 functions, at least in part, through modulating NRF2 and HIF-2a.
To test these hypotheses, we propose two specific aims: (i) To determine the role of JMJD4 in breast
cancer cells. (ii) To reveal how JMJD4 acts through NRF2 and HIF-2a.
Completion of these studies will greatly advance our mechanistic understanding of JMJD4 and its role
in breast tumors. Furthermore, our research may nominate JMJD4 as a novel target for the treatment of
breast cancer. Because JMJD4 is not essential for normal cells, small molecule inhibitors of JMJD4
enzymatic activity are predicted to have minimal side effects, a highly desirable feature. Lastly, insights
gained here likely have implications for the treatment of other diseases, including colon and lung cancer,
where JMJD4 is also overexpressed.

Public health relevance
PROJECT NARRATIVE – ROLE OF JMJD4 IN BREAST CANCER Breast cancer constitutes the second most lethal malignancy for women in the US, indicating the dire need to develop novel efficacious therapies. Our research will elucidate how the JMJD4 enzyme facilitates the development of this disease. This may also nominate JMJD4 as a potential novel target for therapy in breast cancer.